Administrative Core

SUMMARY ADMINISTRATIVE CORE
The Administrative Core of the Antiviral Drug Discovery and Development Center (AD3C) will provide a key
role in leadership, communication, coordination and oversight of the projects and cores, and stimulate
collaboration and synergy between the projects. Operationally, it is in charge of fiscal and contractual
management of the center and will plan and implement activities, such as meetings of the Executive
Committee (EC), external Scientific Advisory Committee (SAC), and an annual meeting of all projects and
cores. In addition, it will manage the inter-institutional cooperative agreements. Finally, the core will facilitate
dissemination of progress and discoveries to the public.